Optimizing HIV-specific T-cell responses by therapeutic vaccination

PROJECT SUMMARY/ABSTRACT
Despite the success of modern anti-retroviral therapy (ART) in limiting HIV replication, HIV infection remains a
chronic disease creating a substantial burden for both patients and the healthcare system. Moreover, it has
become evident that long-term ART will not eliminate HIV, forcing patients to stay on life-long therapy with all
its deleterious side effects. Thus, efforts to eradicate HIV infection, or at least induce a state of viral control and
drug-free remission are needed. As the virus integrates into the host genome of long-lived T cell populations, it
can persist in a latent state creating the viral reservoir and while HIV-1-specific cellular immune responses can
partially control virus replication, e.g. as observed in the small subset of HIV elite controllers that have
undetectable viral loads in the absence of ART, they have failed in the majority of HIV infected individuals to
control or eliminate the viral reservoir. Therapeutic vaccines have been considered to augment virus-specific
immune responses to improve host control of virus replication and reduce the size of the viral reservoir.
However, frequent viral escape mutations in the reservoir have challenged this concept and thus a therapeutic
vaccine strategy will need to induce T-cell responses that have not already experienced immune selection
pressure. One strategy to induce broad cellular immune responses is to utilize bioinformatically optimized HIV-
1 “mosaic” antigens and preclinical data from the non-human primate model confirm that these vaccines
expanded cellular immune breadth and result in a significant reduction of median setpoint plasma simian
immunodeficiency virus (SIV) levels following ART interruption. Thus, we hypothesize that HIV-specific CD4
and CD8 T-cell responses in chronically infected ART-suppressed individuals can be optimized via therapeutic
vaccination with an ad26/MVA vector based vaccine expressing mosaic Gag/Pol and Env epitopes to 1) target
novel and/or subdominant epitopes, with 2) cross-reactive T-cell receptor (TCR) clonotypes which 3) will result
in enhanced antiviral T-cell efficacy against reservoir viruses. We therefore propose 1) to fine map T-cell
responses pre- and post-vaccination, 2) to apply state-of-the-art sequencing technology to determine changes
in TCR-repertoire and function and 3) to determine antiviral CD8 T-cell activity against segments of HIV-1
reservoir viruses. Collectively, in this proposal we aim to systematically determine the ability of a cutting edge
vaccine regimen to induce functionally enhanced and anti-reservoir T-cell responses with the goal to inform the
rational design of therapeutic vaccines optimized for functional HIV cure strategies.

Public health relevance
PROJECT NARRATIVE HIV infection remains a chronic disease requiring life-long therapy and creating a substantial burden for both patients and the healthcare system, therefore, efforts to eradicate HIV infection, or at least induce a state of viral control and drug-free remission are needed. This proposal examines the potential of a novel vaccine strategy to enhance the body's immune response to better control the virus and destroy HIV infected cells. The insights generated in this proposal will help maximize efficacy of current and future therapeutic vaccine strategies.